Composite Integrative Passive Sampler (CIPS)

PROJECT SUMMARY Environmental exposure to chemicals has been linked to serious human health problems, contributing to as many as 1.3 million deaths and 5-10% of all disease burden globally each year, and high economic costs ($340 billion in US and $163 billion in EU). Much of this exposure comes from contaminated water and in the US alone, there are 155,000 public drinking water systems and 16,000 municipal wastewater systems that discharge to surface water; each of these is required by regulators to monitor for chemicals. At the same time, we know that nearly all human health risks from organic chemicals in drinking water are due to low concentration, long-term chronic exposure and not short-term acute poisonings. This poses a technical challenge to detect trace levels of chemicals (e.g., low ng/L) and provide a long-term average exposure when temporal variability often can be 1-3 orders of magnitude from one sampling event to another (e.g. monthly grab sampling). The founders of Statera have invented a novel concept of fabricating a mixed-phase polymer PSD (patent pending) ? the Composite Integrative Passive Sampler (CIPS). CIPS is composed of a continuous mesoporous sorptive phase embedded in a supporting microfiber membrane that sequesters both polar and nonpolar organic chemicals from water. CIPS is a new generation of PSD that will overcome key limitations of competing technology and revolutionize environmental monitoring for organic chemicals in water, with potential for further applications in air, soil, and sediment. The overall aim of this Phase I proposal is to develop an initial CIPS prototype to accurately measure the TWA chronic exposure to over 200 chemicals in water (targeted quantitative analysis), assess the ability of CIPS to capture thousands of other organic chemicals in water (nontargeted qualitative analysis), and compare the performance of CIPS to existing technology.

Public health relevance
Narrative Environmental exposure to chemicals has been linked to serious human health problems, and understanding and managing the risks of these chemicals require accurate measurements of chemical exposure. This project is to develop a disruptive technology and new generation of monitoring for organic chemicals in water providing a major advance in answering the question – Is my water safe to drink?